Core C. Biostatistics Core

ABSTRACT
The Biostatistics Core is responsible for providing statistical support to all projects. The Core will lead or assist
in the development of all study databases and will lead their statistical analysis. The Core will perform a large
variety of modeling tasks ranging from survival analyses using either relative risk (Cox) models or excess
relative risk models. The Core will provide analysis of DNA methylation data including quality control, data
normalization, software selection, and outcome analysis, and perform epigenome-wide association studies of
quitting duration, and lung cancer risk. The Core will assist in the development of a CYP2A6 genetic score and
in the application of this score to the analysis of lung cancer case control data. The Core will also provide
analysis of ethnic and smoking differences, for targeted and untargeted adductomics data, Most statistical
analysis will be performed using existing R or SAS procedures. In some cases, new statistical methodology
may be developed if existing statistical procedures are inadequate for analysis.

Public health relevance
NARRATIVE The Biostatistics Core uses advanced state-of-the art computing techniques to analyze the extensive and complex sets of data that are generated in this Program Project. These analyses enhance our understanding of the interplay between genetic and environmental effects leading to new insights for prevention of lung cancer.